Discovery and validation of single cell biomarkers for clinical outcome in sickle cell disease

PROJECT SUMMARY
There is an urgent and unmet need for pathophysiologically relevant, clinically validated biomarkers for SCD.
We know from numerous studies and decades of experience that the lack of validated biomarkers for SCD
severity results in suboptimal care and a lack of objective outcome metrics for clinical research. Even as
therapeutic development is rapidly advancing, the lack of robust quantitative biomarkers also severely impedes
optimization of proposed treatments, prioritization of distinct treatment modalities, as well as assessment,
approval, implementation, and comparison of candidate treatments. We have known for more than a century
that polymerization of sickle hemoglobin (HbS) and subsequent RBC biomechanical change is the fundamental
pathologic event in SCD. Despite the dominant role of HbS polymerization in disease pathology and treatment
mechanisms of action, there are no clinically validated assays to measure single RBC HbS polymerization and
stiffness increases that drive the disease. Our team developed the first assay to quantify the distribution of HbS
polymer among a population of RBC over the physiologic range of oxygen concentration. Moreover, we recently
demonstrated the clinical utility of these measurements to distinguish patients who received gene therapy in a
clinical trial from those receiving standard of care hydroxyurea even when the two groups have similar levels of
fetal hemoglobin (HbF). To further the potential sensitivity of these measurements, we recently demonstrated
that we could combine high throughput measurement of single cell HbS polymer content with high throughput
measurements of single cell mechanical properties. Thus, we have developed a platform capable of
characterizing blood samples based on the key mechanisms that drive the downstream pathologies in the
disease. We hypothesize that this combination of RBC biochemical and biophysical properties could serve as a
more robust clinical predictor of adverse outcomes than existing measurements. In the proposed studies, we will
(1) Define the relationship between common SCD adverse clinical outcomes and single cell biochemical and
mechanical properties to identify the most promising biomarkers; (2) Define the relationship between favorable
and unfavorable response to SCD treatments and single cell biochemical and mechanical properties to identify
the most promising biomarkers; (3) Develop a platform to measure kinetic changes in single RBC properties
during deoxygenation and identify kinetic metrics that correlate with clinical outcomes in SCD. With a set of
validated biomarkers we can proactively predict odds of an adverse event from steady state values obtained in
clinic and monitor response to a new therapy in a rapid, objective and quantitative manner.

Public health relevance
PROJECT NARRATIVE This work seeks to discover and clinically validate new biomarkers for sickle cell disease that will enable us to proac&vely predict odds of an adverse event from steady state values obtained in clinic and monitor response to a new therapy in a rapid, objec&ve, and quan&ta&ve manner.